AUTORADIOGRAPHIC LOCALIZATION OF ANDROGENS IN HAIR

The purpose of this project is to define the localization of androgens within the hair follicle. It is well known that androgens effect hair growth and that there are regional differences in response. Studies of isolated hairs have demonstrated that hair can metabolize a variety of different androgens but have not explained regional differences. There are no studies which have specifically localized the sites of receptors for androgens within the complex hair follicle and surrounding dermal tissues. Although metabolic studies in isolated hairs have suggested that the steroid pathways may not be the same as in other androgen-dependent tissues, the sites of action of specific androgens in the hair follicle have not been defined. With the advent of sensitive and accurate techniques for the autoradiographic localization of androgens, it now seems possible to define the sites of androgen receptors in hair. I propose to study the localization of tritiated testosterone, dihydrotestosterone, androstenedione and dehydroepiandrosterone in three models: 1. androgen-dependent hair overlying the flang organ in the Syrian hamster; 2. human hair in skin biopsies from different anatomic sites in volunteers and patients with disorders of hair growth; and 3. hair follicles in tissue culture. The long term objectives of the study are four-fold: first, to further understand the metabolic function of androgens in hair by defining which cell types witin and around the hair follicles possess androgen receptors; second, to elucidate regional differences in androgen responsiveness of hair on the basis of the pattern of localization of androgen receptors; third, to define which androgens play an important role in hair metabolism; and fourth, to challenge the validity of previous studies performed on isolated hairs which have disregarded the adjacent tissues left behind when hairs are epilated. Knowledge of the sites of androgen action within and around the hair follicle will be important for the successful development of anti-androgen therapy in disorders of hair growth such as balding, hirsutism and hypertrichosis. Furthermore, development of an animal model will facilitate appropriate drug studies.